Microcyclone arrays for high resolution bioaerosol fractionation and viable virus collection

PROJECT SUMMARY
Our objective is to develop a multi-stage microscale cyclone technology that will serve as an efficient and scalable
platform for bioaerosol fractionation, enabling more effective studies of fundamental and applied viral aerobiology. The
microcyclones will be designed to isolate selected aerosol size fractions collected from exhaled breath samples,
enabling the distribution of respiratory virus within these samples to be evaluated with high size resolution. Significantly,
the technology will be designed to overcome the limitations of existing aerobiological instruments by enhancing the
dynamic size range, maximum number of collected fractions, resolution, throughput, and bioefficiency. The platform
will take advantage of a high resolution stereolithography-based 3d printing technique to pattern large arrays of
complex microcyclone structures in a monolithic substrate, with multiple arrays placed in series to allow selected
aerosol size ranges to be isolated from the sample flow. The system will further support the integration of a hydrogel
layer within each microcyclone array to allow the capture of live virus for infectivity studies. The microcyclone arrays
will be combined with an established exhaled breath collection system and employed to study the distribution of
influenza virus from infected subjects. To support these goals, individual microcyclone elements will be designed,
fabricated, characterized, and optimized for isolating at least five distinct aerosol size fractions ranging from 200 nm to
10 µm, followed by the development of full microcyclone arrays integrating hundreds of individual separation elements
in a single device. A set of cascaded arrays will be assembled into a reusable cartridge to enable collection of all target
fractions within a single integrated unit, and the resulting cartridge will be interfaced with the existing system for high-
volume exhaled breath collection (the G-II sampler developed in the Milton laboratory). The integrated instrument will
be used to collect exhaled breath samples from at least 15 individuals with active influenza infection for the evaluation
of virus distribution across all size fractions. The study results are expected to validate the technology as a powerful
tool for enhancing our understanding of aerobiology and improving modeling, risk analysis, and mitigation strategies
for a wide range of airborne diseases. Successful completion of these aims will offer a clear view of the potential of the
microcyclone array technology for collection and high resolution fractionation of bioaerosols from exhaled breath
samples. For future steps we envision optimizing bioefficiency of the technology to support culture of collected virus,
scaling the arrays to support environmental sampling at higher flow rates, and extending application of the technology
to the characterization of aerosolized bacteria and fungal spores.

Public health relevance
PROJECT NARRATIVE Evaluating the distribution of pathogens within airborne particles generated during breathing is essential for modeling disease transmission and optimizing mitigation strategies. In this project we propose an innovative microcyclone array technology to enable more effective aerobiology studies by improving the accessible particle size range, throughput, fraction count, resolution, and bioavailability. The aerosol fractionation technology, fabricated using a high resolution 3d printing technique, will be integrated with an established exhaled breath collection instrument, enabling system validation through a clinical study of influenza virus aerosol distribution during tidal breathing.